National Center of Neuromodulation for Rehabilitation (NC NM4R)

OVERALL – PROJECT SUMMARY / ABSTRACT
Rehabilitation crucially requires interaction with the nervous system. Thus, neuromodulation (NM) is a tool
uniquely able to address a large number of conditions and populations through a set of common principles that
underlie an emerging neural circuit-based approach to rehabilitation and medicine. Our foundational belief is that
applying NM to specific networks offers outstanding promise for advancing and improving nearly all fields of
rehabilitation. While having grown over the past five years, the field of NM for rehabilitation (NM4R – the
combination of NM and rehabilitation) is still nascent and is just beginning to clinically impact the practice of
rehabilitation. The renewal of the National Center of Neuromodulation for Rehabilitation (NC NM4R) at the
Medical University of South Carolina (MUSC) builds upon our early successes to facilitate the key steps in the
discovery process that are required to develop the next generation of NM4R interventions and to use these tools
to understand and study neuroplastic nervous system changes associated with rehabilitation. The center
harnesses outstanding expertise in non-invasive NM, rehabilitation, operant conditioning of brain and spinal
networks and animal models of NM4R. teams have formed a cohesive NM4R Community, returning to our center
for multiple workshops and hands-on training experiential sessions, receiving follow-on consultations leading to
pilot awards and extramural funding, and have publishing in peer-reviewed journals. The overarching goal over
the new grant period is to impact multiple priorities of the NIH Research Plan for Rehabilitation (RPR) – most
notably to translational science, pediatric rehabilitation and research design and methodology – by increasing
rehabilitation research workforce access to NM4R approaches and supporting rigorous clinical research to
translate them into effective, evidence-based rehabilitation interventions. Our Specific Aims are to: AIM 1.
Increase the size and diversity of the rehabilitation research workforce with access to NM4R approaches;
and AIM 2. Increase the impact of NM4R approaches. In the proposed renewal, our center will design yearly
strategic activities to focus on impacting RPR priorities. Adjacent fields such as psychiatry are more advanced
in applying NM tools in an emerging circuit-based medical model. NC NM4R will serve a vital purpose by infusing
NM skills throughout the rehabilitation workforce and ensuring early exposure to the cutting edge of NM research
for rehabilitation researchers in all domains.

Public health relevance
OVERALL – PROJECT NARRATIVE The National Center of Neuromodulation for Rehabilitation (NC NM4R) at the Medical University of South Carolina (MUSC) addresses the critical need for focused rehabilitation research infrastructure to support rigorous clinical research and to translate non-invasive neuromodulation for rehabilitation reserach approaches into effective, evidence-based interventions. The Center has become an integrated system for training researchers across the spectrum from postdocs to senior investigators, enabling critical data collection via pilot awards, advancing careers and extramural grant applications through mentored collaborative consultations, convening world leaders in the field to discuss methods and technology, and enhancing rigor and reproducibility through hands-on workshops culminating in a research-ready workforce. In the renewal, we will enhance our strategies to closely align with the priority areas indentified in the NIH Research Plan for Rehabilitation.